PREDICTION OF QUALITY OF LIFE IN CARDIOVASCULAR DISEASE

Modern treatments for cardiovascular disease that enhance survival have increased the need to understand and improve corresponding aspects of quality of life. The overall purpose of the proposed research is to develop an integrative predictive model of long-term quality of life in cardiovascular disease that emphasizes adaptive processes and outcomes. The increasing interest in prevention and health promotion in contemporary cardiovascular care emphasizes reducing risk factors that have major behavioral components, such as smoking, diet, and exercise. Personal and social resources and psychological coping strategies are associated with quality of life both directly and indirectly, through such positive health behaviors. Specific purposes of the proposed research include: 1) Developing and testing an integrative prospective structural equation model of the interrelationships among social resources, coping strategies, positive health behaviors, and quality of life in cardiovascular disease over a four-year time-period. 2) Contrasting predictive findings relating to cardiac illness, stroke, and hypertension with predictive findings from matched-control groups of healthy individuals and individuals with very serious (cancer) and moderately serious (arthritis) noncardiovascular disease. Findings from this research will provide an essential foundation for continued investigation focusing on longer-term changes in health status and quality of life in a planned ten-year follow-up with the present sample. The proposed research will involve secondary data analysis with a large sample of individuals surveyed recently through the Center for Health Care Evaluation at the Stanford University Medical School. The sample includes individuals between the ages of 55 and 65 who used medical services in two large medical centers. Extensive psychosocial and physical health data are available from mail-out inventories at three points in time over a four- year period. Of eligible respondents contacts, 92% agreed to participate in the initial survey, and 89% (1884) of them provided complete data. Participation in one-year and four-year follow-ups approaches 90% of surviving respondents from the previous survey. At the initial testing, 411 respondents (22% reported diagnosed cardiac illness (excluding stroke and hypertension), 83 respondents (5%) reported diagnosed strokes, and 593 respondents (31%) reported diagnosed hypertension. The data base at all three measurement times includes extensive information in the quality of life, positive health behaviors, personal and social resources, and coping strategies domains. Computerized hospital medical records are available for one-third of the sample, and will be used to evaluate the reliability of subjects' self-reports of medical conditions and health status. Group comparisons will be made on two dimensions: illness type and post-illness time interval. Longitudinal analyses will be used to examine causal influences on positive health behaviors and quality of life, and to develop and test an integrative predictive model.